Data Bank and BioRepository Shared Resource

The goal of the Databank and BioRepository Shared Resource (DBBR) is to support the collection of high
quality biospecimens and accompanying demographic and clinical data for cancer research. Used by CCSG
members in all programs, data and samples are made available for studies across the cancer continuum,
providing an effective means for testing hypotheses in a timely and efficient manner, rather than needing to
design and conduct costly and time-consuming studies for data collection and processing. The DBBR offers
CCSG members a full spectrum of services. These include: Project Consultation and Study Design, Provision
of Banked Biospecimens and Data for Research, Enrollment and Collections for Specific Studies, and
Infrastructure for banking external specimens. The DBBR served a total of 55 Roswell users, of which 49
(89%) were CCSG members. In response to evolving needs of CCSG members, the DBBR has ongoing
scientific efforts and projects to optimize the utility of samples collected for multiple uses. The Specific Aims of
the DBBR are: 1) To provide banked samples (serum, plasma, DNA, buffy coat and red blood cells) from
patients and non-cancer volunteers, with linkage to clinical data and tumor samples in the Pathology Network
Shared Resource. Data from an epidemiological questionnaire completed by patients is also available. The
biorepository additionally contains data and samples from visitors, community members, and employees, to be
used as non-cancer controls. Samples are processed and banked within one hour of procurement to prevent
variability in sample degradation, and are stored in liquid nitrogen; 2) To prospectively enroll targeted patients
for specific investigator-initiated studies, for example, serial sample draws obtained prior to any treatment and
at specified time points within the treatment continuum. The DBBR also works with investigators conducting
studies of the microbiome in relation to exposures such as diet and physical activity, and in relation to cancer
treatment outcomes, consenting potential participants and processing and storing samples (saliva, stool,
vaginal, and skin swabs); 3) To provide the infrastructure, expertise and resources for processing, banking,
tracking and retrieval of biospecimens from external independent NCI-funded research studies conducted by
CCSG members. DBBR provides the highest quality service and specimens at competitive prices, with a
subsidized rate to CCSG members. During the next funding cycle, DBBR will 1) enhance high quality
biospecimen collection for the microbiome research group; 2) spearhead obtaining informed consent from
patients for inclusion of their data and samples in ORIEN studies; and 3) continue to optimize approaches for
newer technologies, such as extracting cell-free DNA.